EFFECTS ON CHLORDECONE-POTENTIATED CC14 HEPATOTOXICITY

In recent years, there has been a growing interest in age-related sensitivity to adverse effects of drugs and chemicals. Extensive literature search indicated that with aging physiological response to chemical agents, pharmacokinetics, and pharmacodynamics change. It has been also reported that aging results in genetic disturbances and a decrease in capability of tissue repair in the event of injury. Extensive studies have shown that prior exposure of male and female adult rats to nontoxic level of chlordecone (10 ppm in diet, for 15 days) results in 67-fold amplification of CCl4 hepatotoxicity and lethality. The mechanism has to do with suppression of liver tissue repair resulting in progression of otherwise limited injury, liver failure and death. Such amplification of CCl4 hepatotoxicity and lethality by chlordecone (CD) was not observed in postnatally developing rats owing to active cell division and ongoing tissue repair. The purpose of this dissertation research is to investigate the influence of aging on CCl4 hepatotoxicity and lethality and its potentiation by CD. It is hypothesized that during the entire age span rats will fall into three categories with regard to the sensitivity to CD + CCl4: postnatally developing rats are quite resilient; young adults are quite remarkably sensitive; old rats will experience even higher sensitivity to hepatotoxicity and lethality effects of this combination of toxicity given at individually nontoxic levels. CCl4 hepatotoxicity and lethality are due to diminished capability of hepatocellular regeneration and tissue repair. To test these hypotheses, postnatally developing (5-, 20- , 35-, and 45-days), young adult (60-days), and aged (30 months) male Sprague Dawley rats will be maintained either on normal or CD diet (10 ppm for 15 d). On day 16, rats from each dietary protocol will be challenged either with a low dose (nontoxic) of CCl4 )100 mul/kg, ip) or corn oil. It should be noted that individually neither of these treatments is toxic. Liver injury will be assessed at various time points (0 - 96 hr) by measuring serum enzymes (alanine transaminase & sorbitol dehydrogenase) and total bilirubin, followed by histopathological examination of liver section. Hepatocellular regeneration will be assessed by 3H-thymidine (3H-T) incorporation into hepatic nuclear DNA and will be supported by immunohistochemical staining for proliferating cell nuclear antigen (PCNA)/cyclin. The influence of aging on the expression of TGF-alpha in liver regeneration will be examined using immunohistochemical techniques. Furthermore, age-related differences in protooncogenese (c-myc, c-fos, H-ras, p53, etc...) expressions associated with stimulation or suppression of hepatocellular regenerative activity will be also examined. The findings will likely result in our understanding of molecular mechanisms involved in age- related differences in cell division and tissue repair stimulated upon exposure to low levels of chemicals. This dissertation project will enable us to test a specific hypothesis based on whither age-related differences in tissue repair mechanisms might translate into remarkable differences in the ultimate outcome of toxicities to individual or combinations of toxic chemicals.